SURVIVAL ANALYSES FOR BREAST CANCER TREATMENT PROCEDURES

Data collection and survival analyses for patients undergoing various breast cancer treatment procedures were performed using the GCRC Informatics Core. Treatment evaluation and identification of prognostic indicators are end-points.